Fluorescence Microscope with Live-cell and high-resolution imaging capabilities

Project Summary:
This proposal requests funds to acquire a Zeiss Axio Observer 7 wide-field fluorescence microscope with
Apotome-3 and live cell imaging capability, which will be housed in Texas State University (TX State) shared
resource operations (SRO). Over the past 15 years, TX State has sustained a steady increase in biomedical
research capacity and undergraduate STEM matriculation leading to an increased need for strategic modern
scientific instruments investment to bolster the TX State education and research missions. The acquisition of
the proposed Zeiss Axio Observer 7 microscope will directly strengthen the research programs of three NIH-
supported researchers within the TX State Department of Chemistry and Biochemistry and will enhance the
educational mission of the TX State Biology Department. It will bring new high-resolution imagining capabilities
for studying the basic science of microbes and cancer cell-culture models to the TX State campus. The
requested Zeiss Axio Observer 7 microscope will complement existing shared microscopy resources within the
SRO equipment portfolio while bringing new live-cell imaging and multicolor imaging capabilities to the TX
State research community. The latter will support the diverse (bio)material science and engineering training
programs at TX State. Between the research and teaching major users listed in the grant application, we
anticipate that >90 students/year will gain access to this instrument. This includes ~60 students/year in
microbiology-related laboratory coursework spanning the undergraduate and graduate levels and >25-30
student research trainees/year through engagement in independent research experiences. Through the
strategic placement of the instrument in the TX State SRO portfolio, we have guaranteed resources to facilitate
new user training, routine maintenance, scheduling, standard operation procedure
development/documentation, enforcing lab/equipment safety protocols, and in-depth user training for the life of
the instrument. This new instrument will provide long-term research and instructional resources to engage
students and research trainees in the hands-on operation of modern scientific equipment who are
underrepresented in the biomedical sciences at a resource-limited institution.

Public health relevance
Public Health Statement: Optical microscopes are a critical tool for understanding basic cellular functions which is needed to support basic biomedical research and modern undergraduate and graduate training in the life sciences. The requested widefield fluorescence microscope is requested to bring new modern scientific equipment to enhance the biomedical research capacity and educational mission of TX State University which is an under-resourced and minority-serving institution. Engaging students at institutions like TX State University with many different backgrounds and life histories is important to building the next diverse generation of scientific workers that will make future scientific discoveries and develop new technologies to improve human health.